The role and mechanism of alternative RNA splice variants and gene fusions as drivers of cancer

Abstract
My lab has been the leader in the field of mouse modeling for brain tumors over the past 15 years. We have
developed a suite of genetically engineered mouse models that are demonstrably representative of human
gliomas and other tumor types. These models have been used to inform treatment options for clinical agents,
and this now enables us to propose these models are suitable testbeds for testing potential major improvements
to how these diseases are treated. We have three projects. 1) We are understanding the central role of specific
splice variants of TrkB in embryonic development and oncogenesis throughout the body. The RCAS modeling
system has been used here to show that forced expression of the embryonic splice variant in adult tissues
leads to cancer formation broadly. In this project we will investigate the mechanisms of oncogenesis for this
splice variant and determine if it could be a good diagnostic or therapeutic target. 2) We are now using the
modeling system developed for glioma to address the biology of rare tumors driven by gene fusions. In this
grant we propose to understand the mechanisms of oncogenesis for YAP1 gene fusions in the rare tumors
ependymoma, porocarcinoma and aggressive meningioma (all for which we have YAP1 gene fusion driven
models currently). 3) And, we will use these mouse models to study therapeutic response and identify
therapeutic strategies for these fusion driven tumors including identification of FDA approved drugs that would
intervene downstream of the action of the gene fusion.

Public health relevance
Narrative Human brain tumors are genomic heterogeneous within the tumor population and very large datasets of clinical and molecular data on large numbers of patients have been created. Over the past 25 years, my laboratory has worked on modeling brain tumors in mice and correlating those findings with data from human brain tumor patients and have developed unique big data visualization tools that allow the interactive interpretation of these data. We are now using our mouse modeling technology to understand the biology of rare tumors driven by gene fusions and the role of RNA splicing variants of TrkB in development and oncogenesis.